Mechanistic pathways of the effects of human-animal interaction on depression and psychosocial stress

ABSTRACT
Depression is debilitating, costly, and highly prevalent, representing the leading cause of ill health and
disability worldwide. A majority of US households includes pets. Pets offer a source of emotional
support and previous research has shown that they may help ease depression, anxiety, and stress.
However, longitudinal studies to establish causal relationships or explore mechanistic pathways are
still lacking. The objective of this proposal addressing PAR-18-213, ‘Human-Animal Interaction (HAI)
Research’, is to, for the first time longitudinally, examine the effects of pets in the home on depression
and psychological distress in humans, and to explore potential pathways by studying stress biomarkers
(salivary cortisol-DHEA ratio) and the direct and mediating effects of the gut microbiome and
metabolome in these associations. We will leverage three ongoing large population-based studies –
the Nurses’ Health Study 2 (NHS2, n=116,430), NHS3 (n=47,435), and the Growing Up Today Study
(GUTS), 12,413 children of the NHS2 women, who were 9-14 years old at enrollment in 1996 (88%
with pets). With biennial follow-up, they offer a wealth of repeatedly assessed lifestyle, environmental,
and psychosocial assessments allowing to finely control for their potential confounding in our analyses.
Our primary study aims include an ongoing collection of stool samples from 35,000 participants in the
NHS2, who we will follow after stool collection for depression to include 400 women with/without pets
and incident depression in the current application. In addition, a subcohort of 226 NHS2 participants
(62% with pet) collected detailed, repeated psychosocial assessments including information on pet
attachment, pet owner’s personality dimensions, and stress biomarkers as well as participants’ gut
microbiome; thus, we leverage these microbiome data at no additional cost. Further, embedded in
NHS3, we will initiate a longitudinal ‘Nurses’ Pets Study’ (NPS), enrolling pets of nurses into active
follow-up for future HAI studies.
Our chief hypotheses are that pet ownership/attachment reduces risk of incident depression and
psychological distress, and that primary pathways include an improved cortisol-DHEA ratio and
alterations in the gut microbiome, offering the potential for new therapeutic approaches and evidence-
based advice regarding the introduction of a pet into one’s home.

Public health relevance
PROGRAM NARRATIVE Many households include a pet, but whether pets have a positive impact on the mental health and psychological distress of their owners has not been studied rigorously. We will conduct the first prospective study to investigate whether pet ownership and attachment are associated with incident depression and psychological distress in two large US cohorts. In addition, we will explore the role of the gut microbiome and metabolome in these associations, and take first steps towards an embedded longitudinal study of pets and their feces microbiome, for future HAI studies.